Effects of Preconception Care on Maternal Outcomes in Medicaid

ABSTRACT
Maternal mortality and severe maternal morbidity (SMM) continue to rise in the United States, and women from
low-income communities, minoritized racial/ethnic groups, and those with Medicaid or who are uninsured face
increased risk. Hospital care at the time of delivery, and prenatal care during pregnancy, both occur late in the
progression of conditions that are important to maternal outcomes. Therefore, expanding access to
preconception care is a promising approach to improving maternal health and outcomes. Evidence-based
preconception interventions include counseling patients on healthy behaviors (e.g. taking folic acid), managing
chronic health conditions, and providing contraceptive care to plan timing of pregnancy. For many low-income
women, a major barrier to receiving preconception care has been lack of health insurance coverage. The
Affordable Care Act (ACA) reduced the uninsured rate among reproductive age women, giving women greater
access to preconception care. Some states began implementing the ACA’s Medicaid coverage expansion in
2014, and women’s report of receiving counseling on preconception health increased significantly in Medicaid
expansion states compared to non-expansion states. Prior research has identified an association between
preconception care and decreased risk of SMM, particularly among women with a chronic disease. However,
further research is needed to establish a causal effect. This study will harness the study team’s access to
nationwide Medicaid claims data and leverage Medicaid expansion as a natural experiment to estimate the
causal effect of preconception care on SMM for women insured by Medicaid. Analyzing existing Medicaid
claims data will allow us to describe change in preconception care and SMM rates in expansion and non-
expansion states (Aim 1). We will then use quasi-experimental design enabled by variation in state policy (i.e.
timing of adopting Medicaid expansion) to estimate the causal effect of preconception care on risk of SMM,
both in the Medicaid population overall and in sub-groups at highest risk based on medical history (e.g. chronic
disease or history of prior SMM) or sociodemographic characteristics (Aim 2). We will also gain the nuanced
perspectives of patients at high risk for SMM and clinicians who care for them, using qualitative focus groups
and key informant interviews (Aim 3). By combining quantitative Medicaid claims and qualitative analyses, we
will identify preconception interventions and approaches with high likelihood of reducing SMM, particularly for
women at highest risk. We will translate these findings to develop a novel preconception care model that will
be tested in future work.

Public health relevance
PROJECT NARRATIVE Maternal mortality and severe maternal morbidity (SMM) continue to rise in the United States, and women from low-income communities, minoritized racial/ethnic groups, and those with Medicaid or who are uninsured face increased risk. This study will combine quantitative Medicaid claims and qualitative key informant analyses to examine the potential impact of preconception care in reducing maternal SMM, particularly for women at highest risk.